Elucidating the neural mechanisms behind transcranial direct current stimulation

PROJECT SUMMARY/ABSTRACT
Transcranial direct current stimulation (tDCS) is a noninvasive neuromodulation method in which direct
current is passed through scalp electrodes. The current flows through the scalp, skull and CSF before
creating a weak electric field in the brain and causing membrane polarization in cortical neurons. Over the
last 20 years, thousands of studies have highlighted many wide ranging tDCS effects on perceptual, cognitive
and motor function. More recently, clinical trials have begun to assess the effectiveness of tDCS in treating
mental illnesses such as addiction, depression and schizophrenia. However, in spite of the massive amount
of financial and scientific resources directed towards tDCS, there is considerable debate about its
effectiveness and reproducibility. Perhaps even more surprisingly, the basic mechanism though which tDCS
exerts these effects remains unknown. The aim of this project is to answer this fundamental question by
elucidating and understanding the mechanisms driving the reported tDCS effects. In addition to the
neuromodulatory effects caused by direct polarization of cortical neurons, tDCS also stimulates cranial and
cervical nerves in the scalp that give indirect input to the brain. Potential effects from this indirect tDCS
neuromodulatory route have been largely overlooked by the field. This project will combine healthy volunteer
and animal experiments to investigate a range of potential tDCS mechanisms. Healthy volunteer’s
experiments will use careful controls and pharmacological blockers to probe the potential mechanisms that
are driving tDCS effects. Animal electrophysiology experiments will be used to test the validity of and to
provide insight into these mechanisms. Given the current issues in the tDCS field, the deeper mechanistic
insight provided by this project will be vital in advancing the tDCS field at this critical juncture. The new insight
provided by this project will help direct financial and scientific resources towards the development of improved
noninvasive neuromodulation therapies, which can then more effectively treat a wide range of neurological
and psychiatric disorders.

Public health relevance
PROJECT NARRATIVE Noninvasive neuromodulation methods hold great promise for treating a wide range of neurological and psychiatric disorders. However, reported effects are often small, difficult to reproduce and the basic mechanisms underpinning them are not clear. Understand the basic tDCS mechanism is the first step towards improving noninvasive neuromodulation methods, leading to improved therapies for neurological and psychiatric disorders.